Diversity Research Supplement for Combining Experiments and Computer Simulation to Improve the Stem Cell Differentiation Process

ABSTRACT
The overall goal of this work is to determine the characteristics of the motion of micro-sized and nano-sized par-
ticles in a ﬂuid, which has direct application to the study of the motion of intracellular contents during stem cell
differentiation proposed in the parent grant. A clear assessment of the ﬂuid properties is needed because it has a
great impact on the accuracy of the computer simulation of stem cell differentiation. An optical tweezer apparatus
will be used to observe the motion of micron-sized and nano-sized beads as they approach the tweezer's focal
point to determine whether their motion is overdamped, underdamped or even critically damped. The ﬂuid vis-
cosity will also be varied to replicate that of cytoplasm and nucleoplasm. The idea is to characterize the transition
between overdamped and underdamped motion and the conditions under which this transition occurs, if it occurs.
This assessment is important because the proposed model of the cell includes objects of a size above and below
that where the transition should occur. The result of this study, along with those proposed in the parent grant,
should facilitate the development of an accurate high-speed model of stem cell differentiation that can assist in
ﬁlling gaps in the current understanding of cellular mechanobiology, and facilitate future studies of other cellular
mechanobiological processes such as wound healing. This study should also result in a combined experimental
and theoretical optical tweezer tool for exploring the mechanobiology of cells.

Public health relevance
NARRATIVE This project combines modeling and experimental approaches to develop a high-speed computer simulation of long term cell mechanobiology. A key element of the work is a more extensive characterization of the ﬂuid properties within a stem cell and its nucleus, which will allow us to tune our high-speed computer simulation to more accurately predict the outcome of stem cell differentiation. This will further the development of optical tweezer technologies for characterizing mechanobiological properties of cells, which can be used to facilitate the study of many different cellular functions that are governed by mechanobiological processes.